PHYSICAL AND METABOLIC ABNORMALITIES OF LIPODYSTROPHY

The purpose of this investigation is to study patients with various types of lipodystrophies and their family members, to determine the mode(s) of inheritance and to identify lipodystrophy-related candidate genes. Furthermore, the study will determine the natural course of the disease in patients with lipodystrophies through clinical and laboratory investigations.